Neonatal gut-on-a-chip platform for high content drug testing and precision medicine

Project Summary/Abstract
The goal of this proposal is to investigate the role of a human microphysiologic intestine-on-a-chip platform as a
precision medicine tool to model a devastating disease affecting premature infants known as necrotizing
enterocolitis (NEC). We developed preclinical models of NEC using both organoids and a “NEC-on-a-chip” model
system to recapitulate the intestinal environment of the human disease in vitro, gain new insights into disease
pathogenesis and test the functional and clinical utility of our models to evaluate the efficacy of candidate
therapeutics. Our NEC-on-a-chip model utilizes a combination of premature infant intestinal organoids along with
human endothelial cells and patient-derived microbiota, to recreate critical aspects of premature gut
pathophysiology. Our preliminary studies demonstrate that co-culture of these components on intestine-on-a-
chip microfluidic devices produces clinical features seen in human NEC such as gut barrier failure with the
breakdown of cellular tight junctions, decreased epithelial cell proliferation, a dramatic increase in the pro-
inflammatory cytokine response, as well as a significant amount of cell death. In this proposal, we will use several
multi-omic approaches to characterize our NEC-on-a-chip model and compare to the human NEC phenotype.
To achieve this, we developed a multi-center NEC Biorepository, which consists of detailed clinical metadata
corresponding to a plethora of human specimens, including intestinal organoids cultured from the biopsies of
premature infants with or without NEC. Furthermore, we have created a high-throughput and high-content drug
screening platform using premature intestinal organoids to identify drugs or compounds that inhibit the
pathogenic inflammatory responses seen in vitro. Moreover, we will demonstrate the functional and clinical utility
of our patient-derived NEC-on-a-chip model as a precision medicine platform to test the dosing, efficacy, and
toxicity of candidate therapeutics. To successfully complete these studies, we established a multi-disciplinary
team with the expertise of a Neonatologist, Cell Biologist, Pediatric Surgeon, Genome Scientist and
Bioinformatician. Taken together, these studies will make a significant conceptual advance in our understanding
of the multicellular interactions with the microbiome of the developing premature intestine and provide new model
systems and preclinical platforms by which the identification and testing of therapeutics for NEC and other
intestinal diseases can be performed in this vulnerable patient population.

Public health relevance
Project Narrative The study aims to utilize high content systems to identify novel therapeutics for the treatment of necrotizing enterocolitis (NEC), a devastating gastrointestinal disease of premature infants. Using a well-characterized human microphysiologic intestine-on-a-chip platform, we have developed preclinical models of NEC, using both organoids and a “NEC-on-a-chip” model system derived from premature infant intestinal biopsies with patient- specific microbiota to recreate their cellular and microbial environment ex vivo. We will use these pre-clinical models of NEC as a neonatal gut-on-a-chip platform for high content drug testing and a precision medicine approach to this devastating disease.